Structure-Function Analysis of Sarcospan

PROJECT ABSTRACT
Loss of muscle cell adhesion is emerging as a common theme in muscular dystrophies. In skeletal muscle, the
dystrophin-glycoprotein complex is located at the sarcolemma and is composed of peripheral and integral
membrane proteins. As a whole, this complex links the extracellular matrix to the intracellular actin
cytoskeleton and provides structural stability to the sarcolemma during muscle contraction. Duchenne
muscular dystrophy, the most common form of dystrophy, is caused by mutations in the dystrophin gene that
result in loss of dystrophin protein and the entire dystrophin-glycoprotein complex. My research group has
pioneered several key discoveries related to the function of sarcospan, an integral component of the
dystrophin-glycoprotein complex. We have shown that sarcospan plays an important role in mediating protein
interactions within this complex. Sarcospan affects communication between the dystrophin-glycoprotein
complex and the extracellular matrix. Importantly, we demonstrate that mild sarcospan over-expression in mdx
mice, which possess a mutation in the murine dystrophin gene, rescues muscular dystrophy by stabilizing
expression of a complex of compensatory proteins that is functionally analogous to the dystrophin-glycoprotein
complex, including a7b1 integrin. The current 4R01 proposal builds on discoveries made during the prior
funding periods by interrogating specific mechanisms by which sarcospan ameliorates disease in dystrophin-
deficient mdx mice. We will test the hypothesis that sarcospan enhances a7b1 integrin outside-in and inside-
out signaling. We will investigate the extracellular matrix of mdx muscle that is overexpressing sarcospan to
determine how sarcospan affects the composition, organization, and mechanical properties of the extracellular
matrix. Lastly, we will use our decellularization protocol to isolate the extracellular matrix and test its
interaction with human iPSC-derived skeletal muscle progenitors to test principles of bidirectional
communication in a newly developed in vitro model system. We expect that our results will illuminate
molecular pathways that counter a broad range of muscle wasting disorders due to loss of extracellular matrix
contact.

Public health relevance
PROJECT NARRATIVE Our proposal addresses questions related to how sarcospan, a transmembrane protein expressed in skeletal and cardiac muscles, ameliorates Duchenne muscular dystrophy. We will specifically test the hypothesis that sarcospan and a7b1 integrin enhance mechanosensing functions of dystrophin-deficient muscle. We will investigate cell-extracellular matrix interactions in a newly developed in vitro assay with decellularized muscle.